Mechanisms and biomarkers in aberrant paligenosis-induced stomach tumorigenesis

PROJECT SUMMARY
We study formation of upper gastrointestinal premalignant lesions, as well as their progression to neoplasia. A
key premalignant lesion in gastric cancer, pseudopyloric or Spasmolytic Polypeptide Expressing Metaplasia
(SPEM), occurs when chronic inflammation (usually via the bacterium Helicobacter pylori) leads to death
(atrophy) of acid-secreting parietal cells and a change in differentiation pattern of the other key gastric gland
lineage, the zymogenic chief cell (ZC). We and others have shown that ZCs in SPEM become proliferative and
metaplastic. They do so via a sequence of molecular-cellular events that is conserved across many tissues
and species in scenarios where mature cells are recruited back into the cell cycle in response to tissue
damage. Thus, ZCs undergoing metaplasia undergo an evolutionarily conserved program, termed paligenosis.
In paligenosis ZCs: first degrade/recycle their differentiated cell specialized components (Stage 1), then induce
expression of more progenitor-like genes (eg. Sox9 = Stage 2), and ultimately re-enter the cell cycle (Stage 3).
Metaplasia can resolve as tissue is repaired or become chronic and increase risk for progression to dysplasia
and cancer. We have shown that paligenosis is governed by dynamic changes in mTORC1, the key cellular
translational control complex. mTORC1 is elevated at baseline in ZCs to drive production of digestive
enzymes; it shuts off at Stage 1 and reactivates at Stage 3. Without mTORC1, paligenosis stops at Stage 2
with cells looking metaplastic but unable to enter the S-phase.
Here, we explore the mechanisms underlying progression through paligenosis. Our overarching
hypothesis is that paligenosis is a licensing procedure to ensure that old cells, which may have accumulated
mutations and have damaged organelles, undergo a strict error-checking protocol before being allowed to
reenter the cell cycle. Errors in paligenosis may lead to tumors as cells with mutations may inappropriately
proliferate. In the current proposal, we focus on mechanisms regulating Stage 1 and Stage 3 and determine
effects on tumorigenesis with correlation to humans. We undertake these studies with our long-standing
collaborators at China Medical University in Shenyang, China. They provide vast tissue databanks of normal,
metaplastic, and cancerous stomach tissue with accompanying clinical data. And they have established
pipelines for sequencing and bioinformatic analysis. Our Aims are: 1) to determine effects of cells either being
stuck or skipping Stage 1; 2) to elucidate the effects of altering the p53-mTORC1 hub that determines Stage 3;
and 3) to translate our findings towards human relevance using long-term tumorigenesis models with mouse
mutants in cycles of paligenosis as well as correlation in mouse/human ex vivo organoids and in tissue
microarrays of ~1000 human patients.
Together, our combined US-China teams will bring resources and expertise to bear on a global,
understudied health problem with particularly high prevalence in Northeastern China: gastric cancer.

Public health relevance
NARRATIVE Gastric cancer is a global health problem, especially in Northeastern China. This application is for a collaborative approach harmonizing US and China partners. The US group will investigate basic science mechanisms of genes involved in how precancerous lesions (metaplasias) arise, and the Chinese group will provide appropriate clinical samples of patients with gastric cancer. The Chinese group will also help with sequencing and modeling the tumor-forming aspects of specific genes in mice.